Vector Biology: Emerging Concepts and Novel Technologies

ABSTRACT Support is requested for a Keystone Symposia conference entitled Vector Biology: Emerging Concepts and Novel Technologies organized by Drs. João Pedra, Elena A. Levashina and Maria-Carla Saleh. The conference will be held in Breckenridge, Colorado from February 15-18, 2021. Arthropod vectors transmit several infectious agents that infect millions of people globally and cause over 700,000 deaths annually. Rapid unplanned urbanization, increased travel and trade bring humans into frequent contact with arthropod vectors, while climate change fuels their spread worldwide. Innovative concepts and technologies are strengthening vector control worldwide and redefining how to study these arthropods. Therefore, this Keystone Symposia conference will focus on cutting-edge areas of research, such as synthetic biology, microbiome and immunometabolism. The program was designed to embrace the reinvigorated aspects of arthropod vector epidemiology, physiology and reproduction. Furthermore, this conference is being held jointly with “Skin and Immune Crosstalk at Barrier Surfaces”. Entomologists, immunologists and microbiologists will discuss emerging insights into critical molecular mechanisms that occur at the vector-host interface. This conference will provide a collegial forum for intellectual exchange between investigators at various career levels, which will help to generate original thinking to tackle the complexity of vector biology. Currently, there is no high-profile venue to discuss biological mechanisms and disease transmission that occur and are influenced by arthropod vectors as well as the fundamental interactions between vectors, pathogens and host. The program will develop and explore central paradigms in vector biology, foster collaborations between investigators with distinct expertise and provide mentoring for the next generation of scientists.

Public health relevance
PROJECT NARRATIVE Vector-borne diseases threaten humans and livestock on every continent and can transmit several infectious agents that infect millions of people globally, including devastating infectious diseases such as malaria, encephalitis, Dengue and Zika virus, sleeping sickness and schistosomiasis. This Keystone Symposia conference is dedicated to the understanding of arthropod vector biology and host immune interactions in the context of disease transmission. Collectively, this conference will deliver a scientific framework to conduct basic and translational science over the next five years in the field of arthropod vector biology.